Core B: Alzheimer's Disease Down Syndrome Outreach Recruitment and Education (ADDORE)

ADDORE Core Abstract [Revised]
There are numerous barriers to research participation in Down syndrome (DS) that are also complicated by health disparities. The overarching goal of the ADDORE Core is to generate appropriate materials, in collaboration with community at large, for increasing awareness and engagement of adults with DS from all communities into research aimed at understanding and treating AD in this population. We will generate and disseminate educational materials regarding the importance of research and research methods targeting AD in adults with DS and increase recruitment of individuals with DS into the ABC-DS cohort from a broad range of populations and retain existing ABC-DS participants. Successful and unsuccessful outreach strategies will be constantly monitored for updated best practices to be provided to the scientific community. Increased enrollment of adults with DS from a range of populations and retention of existing participants will be the metric for success. This core represents a unique opportunity to engage researchers and community stakeholders to inform best practices for increasing engagement within the DS population.